Project 4: Therapeutic Targeting of Replication Stress Vulnerabilities in Small Cell Lung Cancer

Project 4 Project Summary/Abstract
The goal of this project is to develop novel, synthetic lethal, replication stress related, approaches for SCLC
patients based on their tumor’s molecular profiles. There are two major unmet needs for SCLC therapy: first,
the majority of patients will experience primary or acquired resistance to clinically available chemotherapy and
immunotherapy; and second, despite new data supporting molecularly and biologically distinct subsets of SCLC,
there are no established approaches for biomarker-driven personalized treatments (such as is standard for
targetable oncogenic drivers in NSCLC). Many of the currently “undruggable” oncogenic changes that are
common in SCLC promote tumorigenesis through replication stress (RS) and genomic instability. These
“hallmarks of cancer” lead to high tumor mutational burden and chromosomal aberrations. SCLCs have a
continuous high degree of RS due to the universal loss of p53 and RB1 function, and frequent activation of
oncogenes such as MYC. In the presence of RS, cancer cells depend on RS responses (RSR), which are a
branch of DNA damage repair responses (DDR), to resolve DNA damage and stalled replication forks. Several
RSR inhibitors are in clinical development, and we have preliminary findings in preclinical models indicating that
SCLC lines, xenografts, and genetically engineered mouse models (GEMMs) are sensitive to agents that target
RSR or that increase RS or genomic instability beyond tolerable levels. The latter group includes aurora kinase
inhibitors (which induce mitotic catastrophe in the setting of high RS levels, as well as directly inhibiting DNA
repair and decreasing replication fork stability) and 6-thio-dG (distinct from the well-known drug 6 thioguanine)
which is incorporated by telomerase positive cells, leading to telomere disruption, and increased RS.
Furthermore, we have recently found that therapeutic targeting of RS (e.g., by inhibitors of Chk1 or PARP)
increases cytoplasmic DNA, resulting in activation of the innate immune response (via the Stimulator of Interferon
Genes [STING] pathway), immune-mediated cytotoxicity, and enhanced response to immune checkpoint
blockade. We hypothesize that: 1. RS targeting (through Aurora Kinase inhibition or telomere disruption) will
lead to synthetic lethality in molecularly-defined subsets of SCLC (Aim 1); and 2. that RS targeting will enhance
response to immune checkpoint blockade in immunotherapy-refractory subsets of SCLC via activation of the
innate immune system (Aims 2 and 3). Specifically, we expect that RS-targeted therapies will lead to replication
catastrophe and cell death in oncogene-driven lung cancers and enhance responses to immune checkpoint
blockade (e.g., anti-PD-L1). We will test our hypotheses in an extensive panel of molecularly characterized
SPORE lung cancer cell lines, patient derived xenografts (PDXs, tumor and circulating tumor cell (CTC)-derived),
GEM-derived animal models (Aims 1 and 2), and in clinical specimens from an investigator-initiated Phase 2
clinical trial (Aim 3) of Aurora Kinase inhibition combined with checkpoint inhibitor immunotherapy in extensive-
stage SCLC.

Public health relevance
Project 4 Project Narrative Progress is slow in treating advanced small cell lung cancers (SCLC), and there remains an urgent need to provide patients with long-term durable responses. Approaches to develop SCLC targeted therapy, improve responses to immunotherapy, and to more effectively treat primary chemotherapy relapsed and refractory SCLC are acutely needed. Our Project addresses all of these aspects by testing targeted therapy induced replication stress (RS) as a potential SCLC therapeutic vulnerability which also would increase innate immune responses against SCLC, and lead to improved responses against immune checkpoint blockade immunotherapy. This new SCLC RS vulnerability is studied through a series of preclinical translational experiments and an investigator- initiated Phase 2 clinical trial.